Research Project 2: Molecular analysis of developing post-natal mouse kidney in health and FSGS

Summary
After birth, the kidney continues to develop for weeks in mice, and for months to years in humans. During
this period, the post-natal kidney is undergoing growth and maturation, which requires dynamic changes in
gene expression, metabolism, and physiological functions, and is susceptible to insults causing permanent
morphological changes and functional adaptation. Post-natal growth and maturation of the kidney play an
important role in developmentally programmed diseases. For e.g., children born with a moderate reduction in
nephron number may be more sensitive to metabolic stresses, such as high fat or high salt diet, obesity, and
renal injury from hypoxia or nephrotoxins. Many studies have generated single cell datasets for fetal and adult
mouse kidney. However, in spite of the important role of post-natal insults in development and progression of
CKD, post-natal maturation of the kidney has not been comprehensively investigated at the molecular level
using state-of-the-art technologies. The lack of a reference atlas for this critical developmental period limits our
ability to investigate alterations in cell states and diversity in models of pediatric kidney disease.
Glomerular diseases, including nephrotic syndrome, represent an important cause of childhood kidney
disease. Focal and segmental glomerulosclerosis (FSGS) is a diagnosis that is increasing in frequency, is
often recurrent and treatment resistant, and leads to end stage kidney disease. Secondary glomerulosclerosis
and albuminuria develop in common non-glomerular diseases affecting children, such as CAKUT, and portend
a higher risk of progression to end stage kidney failure. Currently, there are limited therapeutic options to treat
these disorders and a pressing need to better understand disease mechanisms. One of the major mechanisms
by which cells respond to stress or injury is by utilizing the chromatin modifying machinery to reprogram gene
regulatory networks. We developed a novel mouse model of FSGS due to loss of function of metastases
associated protein 2 (Mta2), a core component of the NuRD chromatin remodeling complex. These mutant
mice represent an excellent model to investigate how clinically silent defects in nephron endowment and
altered cell differentiation can manifest as FSGS in late adolescence/early adulthood.
In this proposal we will generate an integrated single cell and spatial transcriptomics mouse atlas
(pKidCAP) at post-natal timepoints that coincide with major physiological and developmental changes in the
kidney. We will determine the evolution of cell diversity, spatial localization, single cell gene expression
signatures and chromatin accessibility states in the developing post-natal kidney in healthy and FSGS tissue.
We will apply ChIP-seq and epigenomic editing to test the hypothesis that de-repression of Jun/AP-1 targets in
Mta2 mutants promotes inflammation, cell senescence and lipotoxicity. Integration of these datasets with the
human pKidCAP atlas (Project 1) will create a unique reference panel to identify pathways uncovered in mouse
models that are highly relevant to kidney diseases in children.

Public health relevance
Project Narrative Currently, there are limited therapeutic options for treating pediatric kidney disorders because of a limited understanding of disease mechanisms. To advance the field, we will use state-of-the-art interrogation technologies to create a molecular atlas of the maturing post-natal kidney in healthy mice and in a model of human disease. The proposed research is relevant to public health and to the NIH’s mission because the information learned from these studies will provide novel insights that may lead to rational therapeutic targets for kidney diseases affecting infants, children and adolescents.